The combinatorial effects of familial mutations, oxidative stress, and aging on BBB dysfunction in Alzheimer's disease

Project Abstract
Alzheimer’s disease is a disease of neurodegeneration and aging that affects millions of Americans, and is
expected to impact millions more without further significant breakthroughs.1 However, much of the etiology
and progression of Alzheimer’s is still unclear, especially given the complex interactions of many different
molecular, cellular, and environmental cues that are correlated with phenotypic outcomes. An emerging focus
in Alzheimer’s study is the role of the cerebrovasculature in the initiation, progression, and exacerbation of
symptomatic disease.2-4 Disruption of the blood-brain barrier, which tightly controls any exchange between
systemic circulation and brain tissue, has manifested in post-mortem and in vivo studies of late-stage
Alzheimer’s disease as microbleeds, dysfunctional glucose transport, and impaired efflux of toxins;5 additional
animal studies have indicated that some vascular dysfunction precedes neuronal degeneration in the
progression of the disease.6, 7 Thus, to understand the drivers and progression of Alzheimer’s disease in
hopes of identifying therapeutic breakpoints, the role of blood-brain barrier dysfunction must be investigated.
To do so, we propose using a tissue-engineered model of the blood-brain barrier with high spatiotemporal
resolution to assess its dysfunction under three key categories of perturbation associated with Alzheimer’s
disease. These perturbations will span cell-intrinsic mutations associated with Alzheimer’s (APP(Swe) and
PSEN(M146V)), extrinsic cues of oxidative stress (hydrogen peroxide exposure), and the systemic influence of
aged blood components (exposure to aged vs. young human serum). We hypothesize that this combinatorial
approach will best recapitulate human BBB phenotype in Alzheimer’s, and allow for modular study of each
contributor. These perturbations will be compared transcriptomically, proteomically, and functionally.
Transcriptomic changes will be studied through bulk RNA-sequencing and gene set enrichment analysis to
highlight similarities to published human datasets, identify hallmark pathways that are impacted by Alzheimer’s
cues, and motivate functional assay design for further validation in the tissue-engineered model. Proteomic
and functional assessments include changes to barrier function, cell identity, and validation of pathways
implicated by transcriptomic analysis. This study will provide a deeper understanding of the role of the blood-
brain barrier in Alzheimer’s progression and emphasize candidate targets for future intervention.
This project and related research training will be conducted under the guidance of Dr. Peter Searson at Johns
Hopkins University and the Institute for Nanobiotechnology. Skills including functional assay design, stem cell
differentiation, microfabrication, and RNA-sequencing analysis will be supported by the educational resources
available within the institution. Additional goals of the fellowship training period will incorporate professional
development for future career success, with an emphasis on communication, mentorship, and leadership skills.

Public health relevance
Project Narrative Alzheimer’s disease impacts 6.5 million Americans and is projected to affect more than 12 million by 2060, if there are no significant advances in prevention and treatment. To address these needs, we must study non- neuronal, but increasingly important, drivers of Alzheimer’s, such as vascular and aging influences. This project will utilize in vitro models to understand these dysfunctions and will contribute significantly to our understanding of Alzheimer’s disease, increasing the scientific potential to design specific therapeutics to reduce illness and disability.